Tri-Institutional Symposium on Reproductive Biology & Infertility (Tri-Repro)

Reproductive health is not only critical for fertility and propagation of the species, but also underlies many key
parameters of human health and longevity. As such, our understanding of the genetic and molecular basis of
key events in reproduction is critical for our ability to improve reproductive health, fertility, and the physiological
well-being of our species. Thus, the primary goal of the current R13 Conference Proposal is to provide a small
local two-day annual conference focusing on reproductive biology and infertility. This event has emerged out of
similar long-standing symposia held by Cornell University’s Center for Reproductive Genomics (CRG) and by
the University of Pennsylvania’s Center for Research in Reproduction and Women’s Health (CRRWH), which
make up two of the tripartite group, the third being the Center for Reproductive Genetics and Therapy (CRG&T)
at Magee-Womens Research Institute (MWRI) at the University of Pittsburgh. The Cornell and MWRI groups
initiated combined symposia in 2018, and over two years, these have been hugely successful. With the inclusion
of UPenn, we have renamed this annual two-day symposium Tri-Institutional Symposium on Reproductive
Biology & Infertility, or Tri-Repro. The second goal of Tri-Repro is to focus on trainee career development by
encouraging participation and leadership from our trainees, and by emphasizing trainee peer-to-peer interactions
through the formation of a tri-institutional Trainee Organizing Committee. Trainees will select up to seven invited
speakers, including renowned leaders in reproductive science from around the world, but also including new
faculty from each of the three institutions. The venue for the symposium will rotate each year, providing a shift
in location, but also encouraging changes in emphasis reflecting the varying interests of each Center. Most of
the talks, and all of the posters, will feature trainee presenters selected by the committee from submitted
abstracts, while a career development lunch forum on day 1 will feature invited speakers who will discuss specific
areas of career development for all trainees. The third goal of Tri-Repro is to provide a local environment to
promote localized interactions and networking with an aim to forge new collaborations between institutions in the
Northeast. This has been the most successful component of our previous symposia: by inviting our neighboring
guest institutions to join us at very low cost (the Tri-Repro group provides all registration and food to our guests,
leaving them with only modest travel and accommodation costs to cover), we provide a rich environment in which
neighboring institutions with interests and expertise in reproductive sciences can come together to discuss
collaborative ideas and provide feedback to each other. Such an environment is often more comfortable and
intimate than large national conferences, allowing even the most timid of trainees to interact with peers and
faculty alike. The fourth goal of Tri-Repro is to champion the inclusion and active participation of women and
people from underrepresented groups in our field, a feature that has been a major focus of our previous
symposia, and which we will continue to prioritize at future events.

Public health relevance
Reproductive health is not only critical for fertility and propagation of the species, but also underlies many key parameters of human health and longevity. This tri-institutional annual symposium will feature reproductive scientists, clinicians, and clinician-scientists in an informal local meeting that will facilitate collaboration and co- operation between institutions that have a strong focus on reproduction and infertility research. The emphasis of this meeting will be on trainee development and will engage neighboring institutions in order to facilitate greater communication among reproductive biologists in the Northeast.